High Resolution, Whole Genome Tracking of Pathogen Transmission and Infection in the Neonatal ICU (NICU)

SUMMARY
Despite reliable use of infection prevention bundles, hospital-acquired infection rates have
plateaued in neonatal intensive care units (NICUs). Our preliminary data from whole genome
pathogen sequencing at Children’s Hospital of Philadelphia (CHOP) suggests that many serious
infections are traceable to strains (highly related clones) that reside in the ICU and are
transmitted amongst patients over time. In this proposal, we aim to determine patient, pathogen,
and environment-specific factors that may contribute to infection risk. In Aim 1, we aim to use
whole genome sequencing (WGS) of bacteria identified from patient colonization, systemic
infection, and colonization of the environment, along with diagnostic allele (DA) surveillance, to
determine the transmission and persistence dynamics associated with bacterial infection within
two NICUs with distinct clinical and demographic characteristics. We will also assess the impact
of patient case-mix and the contribution of NICU layout and environmental characteristics on
observed patterns of colonization and infection. We will use the data from WGS to test DA
sequencing tests as a strategy that can be scaled for broad use as rapid tests in NICUs to
measure strain transmission. In Aim 2 we will assess the impact of providing near real time DA
sequencing to guide targeted deployment of infection prevention strategies by the NICU to
diminish the persistence and transmission of ‘high risk’ strains. The results of this investigation
will demonstrate the feasibility and efficacy of DA sequencing guided targeted interventions to
decrease bacterial transmission and/or colonization and thereby reduce risk of invasive
infection. The findings from this study will be critical to our overall efforts to decrease the risk of
hospital-acquired infection, among our most vulnerable ICU patients.

Public health relevance
PROJECT NARRATIVE S. aureus is a major cause of morbidity and mortality in the neonatal intensive care unit, and efforts at infection prevention have not made further progress in the last decade as infection rates have plateaued. Our preliminary data suggest that a significant proportion of invasive disease in this population stems from bacterial clones that are transmitted and persist over time in the NICU. Our proposal aims to identify the critical factors that characterize the spread and persistence of these clones in the NICU environment, and to design new tools to guide targeted interventions to stop transmission and future disease.